Admin-Core-001

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core is the “nerve center” of the PSC. It provides infrastructure management, administrative
leadership and research, technical and clerical assistance to PSC associates so they can devote as much time
as possible to population research. The core arranges activities that enhance interaction, build community, and
expand exposure to population research to foster interdisciplinary collaboration. The core sets priorities for the
Center, allocates resources, ensures continuing strong University support, and generates an environment that
fosters energetic supportive and stimulating intellectual exchanges within the Center. The cadence of the
administrative Core is in step with the NIH, NSF and foundation deadlines and proactively reaches out to early
career researchers to provide encouragement, interpretation of instructions and formats, timelines and
university policy and procedures. The Core provides specific staffing to the Scientific/Technical and
Development Cores. Coordination by the Administrative Core of shared staff across overlapping functions
makes efficient use of scarce resources. The Administrative Core staff is organized for flexibility and
responsiveness to researcher needs. The staff is cross-trained so there is always coverage of core
administrative tasks. The Core maximizes efficiency for population dynamics research by minimizing the
financial and time burdens of providing administrative support services associated with research projects. The
Administrative Core services and activities are essential to accomplishing the mission and the continued
success of the Center. The Administrative core reduces the structural burden for researcher who seek
extramural funding and frees population scientists to focus on their research. By having a centralized
Administrative Core, staffed with knowledgeable and specialized staff, ready to step in and provide top-notch
service, the efficiency and cost effectiveness of grants development is enhanced. Priority in access to the Core
services is given to junior research scientists.